Cellular Basis Of Action Of Gastrointestinal Peptides/Growth factors

Recent studies show that gastrointestinal hormones/growth factors may stimulate cell growth by stimulating multiple intracellular tyrosine phosphorylation (TyrP) signaling cascades as well as by transactivating growth factor receptors. However at present little is known about the ability of many gastrointestinal hormones/growth factors to activate these cascades. Our studies have been in two general areas, which include studies of intracellular signaling cascades primarily by tyrosine kinases and studies of tumoral growth attempting to develop novel agents for growth inhibition. Recent studies show that gastrointestinal hormones, similar to growth factors, may stimulate cell growth/cell signaling by stimulating multiple intracellular tyrosine phosphorylation (TyrP) cascades. Whereas these cascades have been extensively investigated with growth factors, little is known in this area with may gastrointestinal hormones. The goal of these studies is to clarify this area primarily concentrating on cholecystokinin receptor cascades and bombesin receptor activation using primarily pancreatic acini as a model natural cell system. Studies involving the ability of agonists to stimulate the Bn related orphan receptor, BRS-3 to stimulate growth of lung cancer cells or BRS-3 transfected cells were performed. These studies show that BRS-3 activation stimulates transactivation of the EGF receptor which is dependent on activation of matrix metalloproteinases and the generation of reactive oxygen species. Related studies demonstrated the PACAP receptor activation in various cells results in p125FAK and paxillin tyrosine phosphorylation, two important docking proteins regulating cell motility, adhesion and important in growth. In pancreatic acini, CCK and other PLC activating hormones was shown to activate the novel PKC, PKC theta for the first time and it to play an important role in activating other key signaling cascades. In collaboration with Prof Ito, Fukuoka, Japan, VIP was shown to partially ameliorate experimental pancreatitis by inhibiting oxidative stress through the inhibition of NADPH oxidase.